Reverse transcriptase-mediated expansion of the host innate immune system

PROJECT SUMMARY
Large effect mutations in innate immunity genes can have dramatic effects on infectious disease susceptibility
and outcome. In addition, the genetic determinants of more subtle and widespread variation in an individual’s
susceptibility and immune response to viral infections has been studied in the context of mutations in the many
known innate immunity genes. We propose that there are new polymorphic innate immune genes created by
retroviruses (so called ‘retrocopies’) in the genome of many individuals which are typically overlooked, and which
have the capacity to modulate an individual’s immune response. Thousands of young and old retrocopies are
present in each human genome and their number and sequences differ among individuals in a population. Until
now, old retrocopies have largely been ignored as pseudogenes, while young retrocopies have been
understudied due to technical challenges of accurate identification inherent in the most common sequencing
technologies. A pioneering study in our lab showed that human and other primate genomes contain retrocopies
of the APOBEC3 family of viral restriction factors that are transcribed and capable of restricting virus replication
in vitro. Our more recent preliminary data revealed extensive retrocopying of additional antiviral gene families
within humans and other primate species, suggesting the recent retrocopying of viral restriction and host
dependency factors may be widespread. Further, some of these retrocopies are very young – present in only
some humans – and could represent an unappreciated source of individual variation in susceptibility or
resistance to viral infection. With a combination of computational biology, in vitro virology and biochemistry, and
high throughput functional assays, we will identify young retrocopies of virus-interacting genes that are present
in only some humans and test these new genes’ ability to enhance or impede the innate immune system’s
antiviral response. To test our hypothesis that retrocopy expansions modify immune system function, we will: (1)
Identify young, polymorphic retrocopies of host dependency and restriction factor genes in humans. (2)
Characterize transcription and antiviral functions of polymorphic host dependency and restriction factor
retrocopies, either as restriction factors or dependency factors that evade viral co-option. (3) Identify retrocopies
that act as dominant negative inhibitors of their parental antiviral genes thereby inhibiting the innate immune
system and promoting viral replication. This research will discover new innate immune genes and found a new
direction in understanding the genetic determinants of an individual's susceptibility and immune response to
virus infection.

Public health relevance
PROJECT NARRATIVE When retroviruses infect a host, their reverse transcriptase can sometimes duplicate genes by ‘retrocopying’ host mRNAs back into the genome. Some of these new genes likely contribute to the function of the innate immune system, modifying an individual’s susceptibility and resistance to infectious viruses. Our proposed project will find young and polymorphic retrocopied innate immune genes, assay their ability to promote or restrict viral infection, and begin to define the consequences of overlooked retrocopies on viral infections and human immunity.